mitochondrial DNA leakage promotes inflammation and intervertebral disc degeneration

Intervertebral disc (IVD) degeneration (IDD) is a major cause of low back pain, affecting 39% of American adults
over the age of 18 and costing $87.6 billion in estimated healthcare expenditure. IDD is characterized by
structural and functional deterioration, extracellular matrix degradation, oxidative stress, sterile inflammation,
and impaired biomechanical function in the disc. Mitochondria are endosymbionts derived from bacteria and
contain circular, double-stranded DNA with inflammatogenic unmethylated CpG motifs. Due to its prokaryotic
nature, mitochondrial DNA (mtDNA) that escapes into the cytosol is recognized as “foreign” by the cellular DNA
sensing system, cyclic GMP AMP synthase (cGAS) and stimulator of interferon genes (STING), thereby
triggering an inflammatory response. However, the mechanism of mtDNA escape is not fully understood. The
mitochondrial permeability transition pore (mPTP), a multiprotein complex, allows the passage of small
molecules through the mitochondrial membrane. As mtDNA is large, its escape through the mPTP requires
cleavage into smaller fragments by mitochondrial endonucleases. Notably, mtDNA is 10-20-fold more susceptible
to ROS-induced DNA damage than nuclear DNA. Based on a rigorous review of published studies on mPTP,
cGAS/STING pathway, and mtDNA in chronic inflammation in disc and cartilage, we hypothesize that “oxidative
damage to mtDNA under pathological conditions leads to its fragmentation, allowing its escape through the
mPTP into the cytosol, to induce sterile chronic inflammation and promote intervertebral disc degeneration.” In
this study, we ask the following key questions: (1) Does oxidative damage to mtDNA result in its fragmentation
and escape from mitochondria? (2) What is the mechanism of escape of mtDNA? (3) Does mtDNA escape
induce inflammation in the IVD? (4) What is the mechanism of mtDNA sensing in IVDs? We will employ in vitro
and in vivo approaches using isolated disc cells from human surgical samples and mouse discs, as well as
organotypic cultures of functional spine units (FSU) from mice, and multiple mouse models, including mtDNA
polymerase gamma (PolgA) proofreading mutant, cyclophilin D (CypD) knockout (KO), and Sting KO mice. We
will perform disc needle puncture surgery (NPS) on the caudal discs of mice to induce IDD and investigate the
role of mtDNA in sterile chronic inflammation and IDD. We will use both males and females in all our in vivo
studies to investigate any sex bias in the disease pathology in these mouse lines. The overall goal of this study
is to examine the impact of mtDNA leakage on inflammation and identify novel therapeutic targets for the
management of IDD.

Public health relevance
This project will explore a novel mechanism of sterile inflammation in intervertebral disc and its association with intervertebral disc degeneration by investigating the role of oxidatively damaged mitochondrial DNA (mtDNA) in inflammation. Our studies will elucidate how cGAS/STING activation by oxidized-mtDNA contributes to inflammation in disc. The results will identify novel therapeutic targets for the treatment of disc degeneration.